The Role of TREM-1 in the Regulation of Allergic Airway Inflammation

In the last 20 years more than 3 million United States military personnel have been deployed overseas and
emerging evidence suggests that deployed personnel have a much greater risk of developing respiratory
diseases such as asthma. Among Veterans Affairs patients who were deployed to Iraq and Afghanistan,
asthma prevalence nearly tripled. Studies conducted by the Department of Defense analyzing military
encounter data demonstrate increased encounters occur for respiratory symptoms, predominantly asthma,
after deployment. One potential explanation is that U.S. military personnel deployed in Southwest Asia and
Afghanistan experience elevated exposures to particulate matter (PM) and other inhalational exposures
including desert dust and burn pit combustion. In particular deployed troops are exposed to diesel fuel
which is extensively used in ground equipment and in many tracked and wheeled vehicles. Thus,
understanding how inhalational exposures trigger allergic airway inflammation (AAI), whether this is
exacerbation of existing disease or precipitation of de novo disease, is a critical need in military population.
Allergen sensitized TH2 cells are required but not sufficient for the development of the allergic asthma
phenotype. It is clear from the literature that not all allergic individuals develop asthma upon allergen
exposure, despite systemic sensitization to airborne allergen. In this application we present compelling
preliminary data that neutrophils promote pathogenic T cell response in the airway following inhalational
challenge.
Triggering Receptor Expressed on Myeloid Cell-1 (TREM-1), exclusively expressed on human neutrophils
and monocytes, serves as a global regulator of immune responses. TREM-1 synergizes with Toll-like
receptors, Nod-like receptors, and damage-associated molecular patterns to increase inflammation in
response to inhalational exposures. We hypothesize that neutrophils modulate T cell responses to allergens
in the airspace in a TREM-1 dependent manner. This hypothesis is built upon a growing body of literature
that demonstrate that neutrophils have an important role in the pathogenesis of AAI and our strong
Preliminary Data in TH2 dominant AAI. We demonstrate that neutrophils are present in high numbers
immediately following allergen challenge in asthmatic subjects’ airways, that expression of neutrophil
receptor TREM-1 exacerbates TH2 dominant AAI in vivo, and that neutrophils modulate T cell cytokine
production in a TREM-1 dependent manner.
In our Preliminary Data, we identify a novel TREM-1 dependent interaction between neutrophils and T cells
that may shed light on the mechanism responsible for the large increase in AAI following exposure to
airborne hazards in military populations. Using a TH2 dominant AAI model, Cre recombinase systems, and
adoptive transfer, we will determine how TREM-1 promotes AAI severity as measured by airway
hyperreactivity, cellular quantification by flow cytometry, cytokine levels, and histopathologic changes. We
will then determine if TREM-1 pathways are responsible for diesel exhaust exacerbation of AAI in this
model. Finally, we will determine the effectiveness of TREM-1 blockade in abrogating AAI following allergen
challenge and diesel exhaust exposures. Using in vitro and vivo systems we will define the role of TREM-1
regulated super oxide in promoting pathogenic CD4 T cell responses using human and murine coculture
systems. The goal of these studies is to identify novel therapeutic targets to modulate or prevent allergic airway
inflammation associated with deployment related inhalational triggers.

Public health relevance
In the last 20 years over 3 million US military personnel have been deployed overseas and emerging evidence suggests that deployed personnel have a much greater risk of developing asthma. One potential explanation is that deployed U.S. military personnel experience elevated exposures to particulate matter and other inhalational exposures including desert dust, burn pit combustion, and industrial and military sources. In particular deployed troops are exposed to diesel fuel which is extensively used in ground equipment and tracked and wheeled vehicles. Diesel Exhaust Particles are the main component of exhaust particulate matter and exposure to increases oxidative stress, TH2 cytokine production and airway hyperreactivity. In this study, we will identify the mechanism by which TREM-1 regulates T cell function in lung to exacerbate allergic airway inflammation following inhalational exposures. Characterization of these pathways may identify novel therapeutics targets to treat and potentially prevent asthma.